EFFECTS OF SOY CONSUMPTION ON ESTROGEN IN WOMEN--PART II

The goal of this project is to evaluate the effects of soybean isoflavones on estrogen and isoflavone levels and action in postmenopausal women. Twenty subjects will consume 3 diets for about 13.5 weeks each; their habitual diets supplemented with an isoflavone-free soy powder (control), a low isoflavone soy powder, and a high isoflavone soy powder. A number of estrogen endpoints will be measured, reflecting estrogen availability, metabolism, excretion and action. Blood, urine, feces, and food dairies will be collected and endometrial histology and vaginal cytology will be evaluated.